Adminstrative Shell

Abstract The Administrative Core, consisting of the Center Director and two part time Administrative Coordinators, will continue to provide support for the mechanisms of evaluation, meetings, and communications that constitute the Center's control, ease of access, accountability, and quality control of the core services.